Pregnancy complications in relation to stroke risk in African American women

PROJECT SUMMARY/ABSTRACT
In the United States, African Americans (AAs) have a stroke risk twice that of Caucasians. The third-leading
cause of death for women, stroke affects women more than men. Physiological changes due to pregnancy
increase risk of stroke during the third trimester of pregnancy and postpartum. There is some evidence,
primarily from Northern European populations, that the elevated risk may persist for years after delivery. The
American Heart Association (AHA) recognizes pregnancy complications as risk factors for stroke in women,
but called for more research among AA women on this topic—especially as AA women have a higher burden
of pregnancy complications and there have been almost no studies on pregnancy complications and stroke in
AA women. We propose to address this information gap in a population with a high prevalence of pregnancy
complications, high burden of multiple life adversities, and a high risk of stroke, in the first large longitudinal
study of AA women for this purpose. The Black Women's Health Study, begun in 1995, follows 59,000 AA
women from across the U.S. and collects data every 2 years. Respondents have reported 1,845 incident
strokes and 96,466 pregnancies since the study commenced. We propose to develop a resource for research
on stroke in AA women by validating the self-reported stroke cases in the BWHS through medical records and
Medicare linkage. We propose to assess whether pregnancy complications (preterm delivery, preeclampsia,
gestational diabetes), individually and jointly, are associated with a higher risk of incident stroke in AA women
in later years. We will also evaluate possible modification of the associations by factors such as healthy
lifestyle (e.g., maintaining healthy post-pregnancy body mass index, healthy diet, non-smoking, physical
activity) or by experiences of adversity (physical/sexual abuse, low socioeconomic status, experiences of
racism and discrimination). We will investigate hypertension, type 2 diabetes, and depression as potential
mediators that underlie the progression from pregnancy complications to stroke. The proposed study will be
the first to address a critical unknown—whether and how pregnancy complications contribute to stroke
incidence in AA women, a vulnerable population at high risk for pregnancy complications and stroke. The study
will advance our understanding of potential mitigating factors postpartum that could lower risk of stroke for AA
women. Knowledge gained from this proposal could inform patients, clinicians, researchers, and policy makers,
and increase awareness' of pregnancy complications as stroke risk factors for AA women.

Public health relevance
PUBLIC HEALTH RELEVANCE African American women experience both high incidence of pregnancy complications and high stroke risk. The American Heart Association has called for research on pregnancy complications in relation to stroke risk among African Americans, as almost no studies on pregnancy complications and stroke have been done in African American women. This proposal will be the first to address this knowledge gap, and findings from this study will add new insights on the pathophysiology of stroke.